Synthetic Hydrogels for Islet Vascularization and Engraftment

Project Summary
Type 1 diabetes (T1D) is an autoimmune disease that, in the U.S., affects 1.6 million people, amasses
$16 billion in annual healthcare expenses, and annually rises in prevalence by 64,000 new diagnoses. Clinical
islet transplantation (CIT), which is infusion of islets through the hepatic portal vein, has shown promise as a
T1D treatment. However, only 50% of recipients maintain insulin independence at five years and the procedure
is currently limited to a marginal subset of T1D patients, in part due to two major limitations: instant blood-
mediated inflammatory reaction and delayed vascularization of islets (>14 days). A significant loss of
delivered islets – 60-80% – occurs within hours to days following transplantation in the intrahepatic site.
Therefore, there is a significant need to establish an alternative transplant site that avoids instant blood-
mediated inflammatory reaction and supports the long-term engraftment of islets. The subcutaneous
site is an attractive extrahepatic site with high clinical potential in terms of accessibility, convenience, ability to
re-dose (if necessary), ease of monitoring, and ease of retrieval (if necessary). However, the unmodified
subcutaneous site is clinically limited due to inadequate vascular perfusion and, as a result, inadequate metabolic
kinetics and low oxygenation. An elegant, facile strategy to promote neovascularization is the biomaterial-
mediated delivery of proangiogenic factors such as vascular endothelial growth factor (VEGF). VEGF
promotes the growth of endothelial cells and is a major regulator of native islet vascularization and development.
The objective of this project is to engineer injectable VEGF-delivering synthetic poly(ethylene glycol) [PEG]
hydrogels that promote islet vascularization, engraftment, and function in the subcutaneous space. We have
previously engineered VEGF-containing hydrogels that promote islet survival, vascularization, and function in
the rodent gonadal fat pad and omentum, sites with high inherent vascularization. My central hypothesis is
that the VEGF-delivering gel can be further optimized to promote islet vascularization, engraftment, and
function in the subcutaneous space, a site with high clinical potential. My preliminary data support this
hypothesis and provide strong scientific premise and feasibility for this application. The overall objective will
be accomplished across three specific aims: 1) Identify VEGF-PEG hydrogel formulations that optimally support
islet vascularization using a vascularized islet-on-a-chip platform; 2) Evaluate the ability of VEGF-PEG hydrogels
to promote allogeneic islet vascularization, engraftment, and function in diabetic rats; and 3) Examine the ability
of VEGF-hydrogels to promote allogeneic islet vascularization and engraftment in the subcutaneous space of
non-diabetic pigs. Expected outcomes for this project include: 1) An injectable delivery vehicle for islets that
promotes islet vascularization, engraftment, and function in the subcutaneous space and 2) Validation results in
a large animal model that will inform future studies in a translational diabetic large animal model.

Public health relevance
PROJECT NARRATIVE Type 1 diabetes (T1D) is a chronic, debilitating disease that arises from the autoimmune destruction of insulin- producing β-cells located within pancreatic islets. Pancreatic islet transplantation has shown promise as a potential T1D treatment but is severely limited in clinical settings due to instant blood-mediated inflammatory reaction and delayed re-vascularization of transplanted islets within the intrahepatic site. The objective of this project is to engineer a synthetic biomaterial platform to induce successful vascularization and engraftment of islets in the subcutaneous space, an attractive alternative transplant site with high clinical potential for cell therapies to treat T1D.